Project 1: Epigenetic stability in senescence and aging

ABSTRACT
In the current funding cycle, we obtained evidence that even in non-proliferating cells the epigenome is
maintained in a state of dynamic equilibrium. Given this dynamic epigenome, maintenance of a specific
epigenetic state (a process for which we coined the term “chromostasis”), and hence phenotype, over the
lifespan is likely a challenge for cells. Consistent with this idea, this PO1 has also shown that age-associated
epigenetic alterations can indeed by detrimental to healthy aging and longevity. One manifestation of the
dynamic epigenome, the so-called “DNA methylation clock”, uses age-associated DNA methylation changes to
calculate a methylation age that is typically a strikingly accurate measure of actual chronological age.
However, the extent to which this clock also reflects biological age (i.e. healthy/unhealthy aging) has not been
fully defined. Recently, we co-discovered the first DNA methylation clock in the mouse and showed its slowing
by multiple diverse pro-longevity interventions (Ames dwarfism, rapamycin and calorie restriction), suggesting
it is indeed a biological clock. This clock largely reflects hypomethylation of genic enhancers within highly
expressed genes. Hence in the renewal of this PO1, we will perform mechanistic and functional studies to
determine the underlying molecular causes and consequences of the clock, and whether a biological clock can
be used to predict future age-associated disease and/or mortality.
The ability of rapamycin, an mTORC1 inhibitor and well known drug-based pro-longevity intervention, to
slow the DNA methylation clock suggests that it may exert its pro-longevity effects, at least in part, via
modulation of the epigenome. Indeed, we have obtained evidence that rapamycin stabilizes the epigenome by
slowing the rate of histone eviction. We will investigate the mechanism and the extent to which this model pro-
longevity intervention exerts its pro-longevity/healthy aging effects via the epigenome.
Histone chaperone HIRA is a DNA replication independent chaperone that deposits histone variant
H3.3 into nucleosomes, controls the dynamic epigenome of non-proliferating senescent cells and is required
for chromatin integrity of these cells. Cellular senescence is a stable proliferation arrest and pro-inflammatory
phenotype (the Senescence Associated Secretory Phenotype (SASP)) exhibited by viable but stressed cells.
Accumulation of senescent cells in aged tissues contributes to tissue aging, in part via the pro-inflammatory
SASP, a likely contributor to “inflammaging”. Our recent studies have pointed to a role for HIRA and histone
H3.3, together with the histone acetyl transferase hMOF and its histone target H4K16, in expression of the
SASP. We will investigate the concerted role of HIRA, histone H3.3, hMOF and H4K16ac in expression of the
SASP, in tissue aging and assess its utility as a target to suppress the SASP and promote healthy aging.